A Novel Transcription Factor-Driven Approach for Mural Progenitor Cells Generation

PROJECT SUMMARY/ABSTRACT
Mural cells, including pericytes and smooth muscle cells, are critical for vascular development, function, and
stability. Dysregulation of mural cells can lead to vascular abnormalities, emphasizing the need for generating
functional mural cells to explore novel therapeutic approaches in vascular disorders, tissue repair, and
regenerative medicine. Human induced pluripotent stem cells (iPSCs) offer a promising method for obtaining
patient-specific mural cells; however, conventional chemical-based differentiation methods are limited in scope
and precision. Inducible transcription factors (TFs) have gained traction as a differentiation strategy, offering
precise temporal control and the potential for simultaneous differentiation of multiple cell types. However,
identifying TFs for mural cell differentiation remains challenging. Our overarching goal is to develop TF-driven
strategies for the effective differentiation of human iPSCs into competent vascular cells for regenerative
medicine. Our group previously demonstrated the successful generation of vascular endothelial cells (iECs) from
iPSCs using ETV2, a pioneer TF. More recently, we identified that another TF, NK3 Homeobox 1 (NKX3.1),
facilitates the generation of mural progenitor cells (iMPCs) from iPSCs. These iMPCs display crucial mural cell
characteristics and mature into fully differentiated mural cells upon interaction with ECs. Our group has also
developed a novel vascular organoid (VO) model that allows concurrent co-differentiation of iPSCs into iECs and
iMPCs and facilitates the maturation of iMPCs. Our central hypothesis is that NKX3.1 dictates mural cell lineage
fate, and its activation can effectively generate iMPCs, introducing a novel method for creating an unlimited
supply of functional mural cells for regenerative medicine. To test these hypotheses and elucidate the
mechanisms underlying NKX3.1-driven mural cell differentiation and maturation, we propose three specific aims.
In Aim-1, we seek to elucidate the transcriptional regulation of iMPC specification using NKX3.1. Aim-2 delves
into the mechanisms of mural cell maturation in the VO model, examining how EC interactions affect iMPC
maturation. In Aim-3, we seek to evaluate the therapeutic potential of iMPCs in ischemic tissues, determining
whether iMPCs can act as a source of functional perivascular cells in vivo, supporting EC engraftment and
contributing to the stability of newly generated blood vessels. We anticipate that these investigations will uncover
the molecular underpinnings of mural cell lineage determination and functionality, ultimately advancing our
understanding of mural cell development and therapeutic potential. This knowledge will pave the way for patient-
specific strategies for treating vascular disorders and advancing vascular regenerative medicine.

Public health relevance
PROJECT NARRATIVE This project aims to enhance our understanding of a type of cell called a mural cell, which plays a crucial role in the health and function of our blood vessels. We plan to utilize cutting-edge techniques to manipulate stem cells, turning them into mural cells, which we will then study in a lab-created miniature organ model. This research will expand our knowledge of blood vessel development and function and pave the way for potential new vascular disease treatments and regenerative medicine advancements.